T RNA MODIFICATION AND GENE EXPRESSION IN MAMMALIAN CELL

We have developed and characterized (biochemically and genetically) the regulation of an amino acid biosynthetic enzyme in CHO cells. We shall now exploit this system at the molecular level.